Cerebral organoid and IPSC derived microglia: Modeling of HIV and methamphetamine co-morbidity

Abstract:
An estimated ~1.3 million adults and adolescents are living with human immunodeficiency virus (HIV) infection
in the USA of which 15% of them undiagnosed. The initiation of combination antiretroviral therapy (cART) has
transformed AIDS from a fatal illness into a chronic and manageable disease. The presence of HIV infected
microglia and macrophage reservoirs in the central nervous system (CNS) and variable penetration of anti-
retroviral drugs across the blood brain barrier after cART are likely factors for the persistence of HIV associated
neurocognitive disorder (HAND). Drugs of abuse such as the potent psychostimulant methamphetamine (Meth)
that is abused by an estimated 30 million people in the world further minimize the efficacy of cART and in
conjunction with HIV exacerbate CNS pathology. Thus, significant gap in knowledge in the field is to better
understand the neuropathogenesis and the etiology of clinical outcomes observed in HIV+ patient’s dependent
on Meth abuse. The current grant proposal focuses on developing a human induced pluripotent stem cell based
cerebral organoid model to investigate underlying brain dysfunction during HIV/Meth interaction. Cerebral
organoids are 3-dimensional “mini brains” that can self-organize and recapitulate many milestone events seen
in in vivo brain development. Our recent study on generating a novel organoid model with the feasibility in
controlling the microglia ratio and microenvironment of organoid formation to recapitulate changes in brain
functions under various conditions (e.g. virus and viral infection-induced inflammation and synaptic pruning)
makes this model ideal for our proposed studies. The central hypothesis of this proposal is that Meth in
conjunction with HIV causes significant neuronal damage. The combination of microglia-containing cerebral
organoid model, extracellular vesicle biology, single-cell RNA-sequencing, CRISPR/Cas9-mediated gene editing
will decipher novel intercellular and molecular mechanisms and pathways that underlie abnormalities in neuronal
functions and connectivity caused by HIV infection. We will investigate this hypothesis under three specific aims:
Specific Aim 1 will examine neuronal function, synaptic and mitochondrial perturbations during HIV/meth
interactions in 3D microglia-containing cerebral organoid model; Specific Aim 2 will investigate the role of
extracellular vesicles in microglial organoids treated under HIV/meth conditions; and Specific Aim 3 will
characterize the molecular mechanisms underlying HIV infection-induced neuronal injury and further evaluate
our microglial organoid model as a reliable tool to identify molecular signatures of HAND. Our proposed
experiments will decipher molecular mechanisms, novel signaling events and molecular partners underlying the
neuronal injury in HAND. Through the series of the experiments we aim to present an easily scalable and
reproducible model to study HAND pathogenesis. The data obtained from these studies can be used to design
novel therapeutics to control HIV infection.

Public health relevance
Project Narrative: Despite the success of cART, high prevalence of HIV-associated neurocognitive disorders (HAND) poses a major challenge for the society. This proposal focuses on the use of a novel 3-dimensional organoid co-culture model to decipher mechanistic pathways that underlie abnormalities in neuronal connectivity as seen in HAND.